FREE FATTY ACID REGULATION OF INTRACELLULAR GLUCOSE METABOLISM

To determine whether in humans, free fatty acids reduce intracellular glucose metabolism by inhibiting pyruvate dehydrogenase, phosphofructokinase and glycogen synthase. This protocol has become a CDMAS protocol for completing analysis and future use.